Neuroscience Resident Research Program

DESCRIPTION (provided by applicant): This is a renewal proposal describing the Research Training Program for Neurology and Neurosurgery Residents at Massachusetts General Hospital (MGH) and Brigham and Women's Hospital (BWH) of Harvard Medical School (HMS). The program combines the exciting variety of collaborative research opportunities available at these campuses with a dedicated core group of neuroscience mentors aligned in a two tiered system which includes a 'gateway' mentor responsible for the overall career development of the R25 candidate and a 'research' mentor directly responsible for the scientific activities of the candidate. Mentors have been carefully selected on the basis of research activity, experience guiding clinicians in the early stages of successful research careers, and commitment to this program to develop neurology and neurosurgery residents into effective physician-scientists. In addition, a steering committee will closely oversee all aspects of the resident research training experience. This program has already had tremendous success in its first 5 years of funding which has included 23 trainees who have produced numerous high-impact first author publications and earned foundation as well as K12 and K23 funding. This programmatic structure builds on these successes to ensure that neurology and neurosurgical residents obtain the highest level of training possible to launch careers as outstanding physician-scientists.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is a widely recognized need for translational and clinical research in neurological diseases which can only be met by continuing to train new investigators who will bring innovative solutions to neurological health problems. This application looks to renew a successful program linking the tremendous depth and breadth of research resources available in the Harvard University system to a small group of dedicated senior neuroscientists mentors for the career development of residents.